Building a unified framework for understanding bacterial gene regulation and chromosomal architecture

ABSTRACT
Transcriptional regulation via protein-DNA interactions plays an important role in the regulatory networks of all known
organisms. Bacterial regulatory networks are now an especially fruitful target for detailed investigation: as antibiotic-
resistant bacteria continue to emerge as a global health threat, new and innovative approaches to either preventing
virulence or impairing bacterial growth are required. As our ability to predict and exploit bacterial behavior for
therapeutic purposes hinges on our understanding of the logic behind their regulatory networks, it is of great utility to
fully map those networks and the molecular mechanisms underlying them.
Several challenges, both old and newly recognized, stand in the way of a comprehensive understanding of
regulatory logic even in well-studied models such as Escherichia coli. In additional to classical cis-regulatory logic by
transcription factors and sigma factors, recent work by our laboratory and others has revealed contributions due to
chromosomal context, large heterochromatin-like regions of repressive occupancy of nucleoid-associated proteins,
overall three-dimensional chromosomal structure, and epigenetic modifications of both DNA-binding proteins and the
DNA itself that further modulate transcriptional regulation. In addition, for non-model bacteria even the fundamental
logic of classical transcriptional regulation is often poorly characterized. Thus, the fundamental regulatory logic behind
cellular decisions such as metabolic switches, motility, and induction of virulence is often under-characterized.
We have developed several innovative technologies to assist in rapid characterization of bacterial transcriptional
regulatory logic, including: IPOD-HR, which allows overall profiling of protein occupancy on bacterial; transposon based
methods for rapidly profiling genome-wide effects of genetic context on transcription; and a method based on the
transposable phage Mu for crosslinking-free measurement of the 3D structure of the genome. Using these methods
alongside classical approaches such as bacterial genetics and ChIP-seq, we are pursuing several avenues of research to
investigate bacterial transcriptional regulatory networks. Key areas of interest include:
Rapid elucidation of new transcriptional regulatory networks: Leveraging the IPOD-HR technology, which we
have shown can be readily applied to new bacterial species, we are mapping the set of cis regulatory interactions driving
important environmental responses in several clinically relevant bacterial species.
Dynamics and composition of extended protein occupancy domains (EPODs): We have shown that highly protein
occupied, heterochromatin like EPODs are present in a broad range of bacterial species, and play key roles in regulating
prophages, virulence genes, and metabolic genes. We will continue to investigate the regulatory roles of EPODs, the
proteins that comprise them, and the factors dictating their formation/dissociation across a range of bacterial taxa.
Interplay of bacterial epigenetic marks with TF binding and EPODs: By interfacing our IPOD-HR and ChIP-seq
experiments with tracking of covalent DNA and DNA-binding protein modifications, we will elucidate how these
modifications modulate both local and large-scale protein occupancy and transcription in bacteria.

Public health relevance
Project Narrative: We have recently shown that several aspects of the structures of bacterial chromosomes play important roles in gene regulation, especially of genes involved in nutrient acquisition and virulence. We will utilize a recently developed suite of tools to determine the contributions of chromosomal structure to the regulation of these processes across a broad range of bacterial species and physiological conditions. Our findings will assist in the design of targeted therapeutics inhibiting bacterial virulence, and enhance our capabilities in designing regulatory circuits for synthetic biology.